Deep molecular and cellular profiling of colorectal cancer tumor and immune microenvironment in Alaska Native people

PROJECT SUMMARY
Alaska Native people have the highest incidence and mortality rates of colorectal cancer (CRC) globally, with
rates that are more than double those observed in the general U.S. population (incidence: 89.0 vs. 38.6/100,000;
mortality: 39.6/100,000 vs. 13.8/100,000). These high rates cannot be explained by access to screening, as
dedicated efforts to increase CRC screening have resulted in screening rates in Alaska Native people that are
comparable to the US average. These disparities have persisted for over 40 years and are of noted concern to
community members and Tribal health leaders alike, making this a priority research area for Alaska Native
people. A key knowledge gap is the lack of sizable and comprehensive studies characterizing the molecular
features of colorectal tumors in Alaska Native patients. Accordingly, we propose an integrative approach to better
understand CRC tumorigenesis and molecular subtypes in this high-risk population, and to evaluate whether
various tumor and tumor microenvironment features contribute to disease progression. Specifically, we aim to
deeply characterize the mutational, transcriptional, and cellular landscapes of CRC tumors and their immune
microenvironments in 500 Alaska Native patients and link these characteristics to CRC-specific mortality. We
will build on our existing collaboration between the Alaska Native Tribal Health Consortium (ANTHC) and the
Fred Hutchinson Cancer Center. We will capitalize on ANTHC’s unique biorepository (linkable to comprehensive
medical records) that contains tumor tissue samples of the majority of Alaska Native CRC patients diagnosed in
Alaska. Pilot data generated using biospecimens from this resource and utilizing the same platforms as proposed
here demonstrate high-quality data and ensure that IRB and tribal approvals are in place to enable rapid
execution of the proposed work. To identify clinically meaningful population differences, we will compare
molecular profiles with those from non-Hispanic White CRC patients using available data. In Aim 1, we will
perform whole-exome sequencing of CRC tumors and paired normal samples to identify driver genes and
clinically actionable mutations particularly relevant to the Alaska Native population. To gain etiological insight,
we will analyze mutational signatures that may be linked to environmental exposures and identify germline
mutations in high-penetrance CRC risk genes to investigate their role in the increased CRC risk in Alaska Native
people. In Aim 2, we will apply two complementary cutting-edge spatial profiling technologies to fully characterize
the tumoral immune response and discover mechanisms of immune evasion. We will perform spatial whole
transcriptome profiling of CRC tumors using Nanostring’s GeoMx Digital Spatial Profiling technology. We will use
Akoya Biosciences’ PhenoCycler platform for spatially resolved single immune cell phenotyping. We expect that
insights gained through this work can inform the development of high-value, novel therapeutic strategies. In Aim
3, we will leverage these molecular data to develop novel predictors of CRC-specific mortality that could help
guide clinical decision making, improve outcomes, and reduce long-standing disparities.

Public health relevance
PROJECT NARRATIVE This project aims to fill a key knowledge gap by conducting an unprecedented evaluation of the molecular landscape of the tumor and tumor microenvironment in a large sample of Alaska Native colorectal cancer (CRC) patients using cutting-edge molecular profiling technologies. Results from this project will improve our understanding of CRC tumorigenesis, molecular subtypes, and clinically actionable mutational, genetic, and immune-related features in the Alaska Native people who experience the highest CRC incidence and mortality rates worldwide. Insights gained through this work may inform the development of novel therapeutic strategies, may result in clinically useful predictors of CRC-specific death that can be used to guide clinical decision making, and, ultimately, decrease mortality.